IP3 METABOLISM AND CA++ HOMEOSTASIS IN CEREBRAL ISCHEMIA

A disturbance of the mechanism for intracellular Ca2+ homeostasis due to cerebral ischemic insult has been implicated in the irreversible damage leading to neuronal cell death. Although several known factors may contribute to the initial increase in [Ca2+]i during the early phase of an ischemic insult, the mechanism(s) leading to the progressive neuronal damage after prolonged ischemia and recirculation is not known. Due to the important role of Ins(1,4,5)P3 as second messenger for intracellular [Ca2+]i mobilization, it is hypothesized that prolonged ischemia- reperfusion results in irreversible modifications, either on the enzymes responsible for metabolism of Ins(1,4,5)P3 or its binding to the intracellular receptor. In turn, changes in Ins(1,4,5)P3 metabolism and/or binding may be an important mechanism leading to the altered cellular Ca2+ homeostasis associated with neuronal cell death. this hypothesis will be tested using a well established rat focal ischemia model (occlusion of middle cerebral artery) that resembles stroke in humans. Specific aims are: (1) In vivo and in vitro experiments to determine the effects of transient (15 min) or prolonged (60 min) ischemic insult on poly- phosphoinositide breakdown and release of inositol phosphates. (2) Experiments to examine the effects of ischemia-reperfusion on metabolism of Ins(1,4,5)P3 by the 5-phosphatase and 3-kinase. Since there is strong evidence that Ins(1,4,5)P3 3-kinase, a key regulatory enzyme for Ins(1,4,5)P3 metabolism, may be irreversibly modified by a number of factors including Ca2+/calmodulin and Ca2+-proteases (calpain), studies will focus on effects of ischemia on the extent of proteolysis and levels of mRNA for this enzyme. (3) To examine the effect of ischemia on Ins(1,4,5)P3 receptor binding activity and the levels of mRNA encoding this receptor protein. (4) Upon establishing these experimental protocols, we will examine the effects of non-NMDA antagonists (NBQX) and protease inhibitors (leupeptin) on their ability to inhibit the ischemia-induced changes in Ins(1,4,5)P3 metabolism and binding. The long term goal is to understand the effects of focal ischemic insult on molecular and cellular mechanisms leading to the changes in intracellular Ca2+ homeostasis through alteration of the poly-phosphoinositide signaling pathways. Information resulted from this project will be important in designing strategies for therapeutic intervention towards alleviating the pathophysiology of ischemic tissue injury.